Training in Environmental Toxicology

Funds are requested to support the Rochester Toxicology Training Program. There are pressing societal
demands to identify and evaluate the impact of an ever-increasing array of environmental chemical, physical,
and social stressors on human health. The overall objective of this Program is to provide pre- and postdoctoral
training for the next generation of talented, independent toxicologists and environmental health scientists with
critical thinking skills who will conduct novel research and actively transform their findings, and findings from
others, into new information. This information will then be translated for use by scientists, public health and
medical professionals, governmental and other agencies, and the public to improve overall human health and
well-being. This Program is distinguished by its exceptional environment for training in toxicology, as evidenced
by the success of prior trainees, the remarkable collegiality and extensive collaborations amongst faculty and
trainees, a broad base of research support, and its strong leadership and institutional commitment. The Program
is dedicated to meeting the needs of trainees from diverse backgrounds and supporting their individualized goals
for careers in academia, government, and industry. The Program’s framework is based on the philosophy that
training for the future workforce requires multidisciplinary and interdisciplinary approaches, close working
relationships between trainees and their mentoring teams, and a culture that supports diversity, autonomy, and
career development. The Program takes advantage of extensive expertise and resources that are available at a
major academic medical center by reaching beyond a single department. The Program is housed in the
Department of Environmental Medicine, yet the 31 faculty mentors come from 13 basic science and clinical
departments and divisions within the University of Rochester School of Medicine and Dentistry. Faculty research
spans the entire spectrum of toxicology, from molecular mechanisms and cellular processes to whole animals
and human populations. There are 7 keystone research areas (Neurotoxicology and Behavioral Toxicology,
Pulmonary & Cardiovascular Toxicology, Developmental & Reproductive Toxicology, Immunotoxicology,
Musculoskeletal Toxicology, Dermal Toxicology and Endocrine Toxicology) that are rooted in contemporary
themes that include particles and air pollution, molecular-genetic modifiers of toxicity, developmental origins of
health and disease, epigenetic regulatory systems, and social determinants of disease. The Program is also
tightly integrated with other training programs, as well as research and professional development support centers
at the University. During the current cycle of this training grant, refinements to the didactic curriculum were
adopted, new environmental health research expertise was added, equity and diversity initiatives were launched,
and strategies to recruit and retain trainees from diverse backgrounds were revised. Continued support of the
Rochester Toxicology Training Program will ensure that a reliable stream of exceptionally well-prepared PhD-
level toxicologists will be ready to meet the growing demands of the today’s health science workforce.

Public health relevance
The Rochester Toxicology Training Program provides research training and career development support for graduate students and postdoctoral fellows who are seeking careers in toxicological and environmental health sciences. This program trains future scientists to apply critical thinking, communication, and investigative skills to identify and characterize the negative impacts of chemicals and other environmental stressors on human health and resolve strategies for improving overall well-being.